A prospective longitudinal study of transactional associations between social, neural, and hormonal changes and adolescent girls' mental health trajectories

ABSTRACT
Internalizing problems are common, harmful, and sharply increasing amongst adolescent girls –
creating a public health imperative to identify mechanisms as well as markers of risk or resilience, spanning
from biology to behavior. It is also essential to identify for whom these issues will be adolescent-limited versus
indicative of persistent or worsening mental health, and understand the reasons why. Core biological and
social processes of adolescence, such as puberty, brain development, and peer relationships, are promising
targets. Socially, building and strengthening close friendships and romantic relationships are central
developmental tasks in mid-to-late adolescence. The quality of close peer relationships in mid-to-late
adolescent girls is known to have bidirectional and nuanced associations with emergence and recurrence of
depression, anxiety, and self-harm. Interrogating this dual nature of close relationships, across timescales from
days to years, is critical to begin addressing the emerging mental health crisis in adolescent girls. Furthermore,
it is necessary to also account for the extended influence of pubertal processes, as puberty itself is strongly
implicated in adolescent girls’ mental health. Ongoing maturation of sex hormones as well as brain structure,
function, and connectivity through late adolescence makes it vital to integrate the contribution of developmental
change in these biological factors to social processes and internalizing problems. The Transitions in Adolescent
Girls (TAG) study, launched in 2015 (R01/R56 MH107418), was designed as a comprehensive multilevel
investigation of the connections between biological and social changes during early-to-mid adolescence, as
mechanisms of risk for the emergence of depression, anxiety, and self-harm. We enrolled a community sample
of N=174 girls (initial ages 10-13 years) into a longitudinal study, with three waves of data collected every 18
months, including two laboratory visits at each wave. The first phase of the TAG study focused on early-to-mid
adolescent mental health, as shaped by pubertal, neural, and social development (self-perception and social
cognition). We propose to collect three additional waves of data, approximately 18 months apart, extending the
cohort’s age range to 21 years. This new phase of the TAG study will have a developmentally-appropriate
multilevel emphasis on close peer relationships, assessed via established questionnaires, daily self-reports,
and novel paradigms that tap into intimate self-disclosure behavior and brain function. It will conduct innovative
analyses to relate daily positive and negative experiences in close friendships and romantic relationships, with
changes in well-being. Finally, it will continue to deeply phenotype ongoing biological (neural, hormonal, and
pubertal) changes, and relate these to antecedent and subsequent social processes and mental health. We
propose that close relationship quality and neurodevelopment during mid-to-late adolescence is not only
predictive of concurrent and near-future mental health, but also part of a cascading series of developmental
and risk processes that are set into motion by earlier biological and psychosocial changes.

Public health relevance
PROJECT NARRATIVE This project provides a comprehensive picture of social, neural, and hormonal changes and their relationship to mental health problems in mid-to-late adolescence, a period of peak symptom severity and diagnosis rates for internalizing disorders and self-harm among girls. Understanding the core mechanisms associated with these problems across adolescence will not only enhance our knowledge of how mental illness develops in vulnerable individuals, but also enable translation of this knowledge for developmentally targeted approaches to early intervention and prevention. This project seeks to inform clinical intervention and prevention approaches that target close peer relationships and leverage biological insights to improve adolescent mental health, specifically through the lens of investigating emergence and recurrence of internalizing disorders in adolescent girls.